Diversity Supplement: Neural mechanisms of meditation training in healthy and depressed adolescents: An MRI connectome study

Project Summary/Abstract of Parent Grant
Meditation training is a promising technique that can help improve emotional health of adolescents and facilitate
treatment of adolescent depression. However, there is a fundamental gap in understanding the neural
reorganization that takes place as a result of meditation training. Continued existence of this gap represents an
important problem because, until it is filled, design of more effective interventions is highly unlikely. The longterm
goal is to establish safe and effective methods of promoting emotional health in adolescents. The objective here
is to study adolescents undergoing meditation training by using MRI connectomics to map changes in node
strength (integrated connectivity) of the putamen. The putamen is a region previously associated with meditation
practice and attenuated shrinkage with age in Zen meditators on the one hand, and with love, compassion,
anticipation of pleasure, and responses to increasing intensity of happiness on the other hand. The central
hypothesis is that structural connectivity of the putamen with other brain regions will increase in adolescents with
meditation training and, in turn, positively affect their emotional health. This innovative model is rooted in
preliminary results and previous literature. The rationale for the proposed MRI connectomics approach is that
regular engagement of the putamen is expected to increase myelination of the white matter tracks connecting it
to other regions, which can be probed by using diffusion MRI. Guided by strong preliminary data, this hypothesis
will be tested by pursuing two specific aims, which entail studying changes in the putamen node strength and
emotional health measured as internalizing problems and depressive symptoms in 1) a cohort of healthy
adolescents with a 12-week meditation training compared to waitlist controls (R61 phase) and 2) a cohort of
adolescents with mild to moderate depression with a 12-week meditation training compared to waitlist controls
(R33 phase). The “Go/No-Go Criterion” is a medium-large increase of the putamen node strength observed
with meditation training in healthy adolescents in the R61 phase (Cohen’s d>0.6). The optimization strategy for
the R33 phase is based on the fact that anhedonia (diminished ability to experience pleasure) is a key
characteristic of depression and preliminary results show that putamen structural connectivity is lower in
adolescent depression. It is therefore expected that the mechanistic effect in the putamen will be amplified in the
population of depressed adolescents, reflecting normalization of the putamen function. The proposed research
is innovative, because it uses advanced MRI connectomics methods to map changes in brain networks of youth
with meditation training and tests a novel mechanistic model. The proposed research is significant, because it is
expected to greatly advance our understanding of the neural mechanism by which meditation improves
emotional health of adolescents. Ultimately, such knowledge will inform treatment and prevention of adolescent
depression.

Public health relevance
Project Narrative of Parent Grant The proposed research is relevant to public health because understanding of the neural mechanism by which meditation training improves emotional health in healthy and depressed adolescents is ultimately expected to help us develop safe and effective methods of treating and preventing adolescent depression. Thus, the proposed research is relevant to the part of NIH's mission to ensure that all youth have the chance to achieve their full potential for healthy and productive lives, free from disease or disability.